Core A - Administrative

CORE A – PROJECT SUMMARY/ABSTRACT
This is a continuing program project with multiple projects, cores, institutions and investigators from the
Zilkha Neurogenetic Institute, Stevens Neuroimaging and Informatics Institute, Alzheimer’s Disease Research
Center (ADRC), University of Southern California, Los Angeles, CA; Washington University Knight ADRC and
Department of Neurology, St. Louis, MO; Huntington Medical Research Institutes, Pasadena, CA; Banner
Alzheimer’s Institute and MayoClinic, Arizona; Department of Psychological Science, UC Irvine; and Department
of Molecular Medicine, the Scripps Research Institute; and Centre for Clinical Brain Sciences, University of
Edinburgh, Scotland will also join the program. The P01 has and will continue to function as an integrated whole
far greater than the sum of its parts. Each project and core complements the others so that a synergistic
relationship among them is achieved with a common focus on goals of the program, namely to test the
neurovascular hypothesis of AD. The Administrative Core is structured to insure that this program functions as
efficiently, productively and transparently as possible. The goals of Core A remain designed to provide effective
scientific and administrative leadership for the program and ensure effective communications across projects
and cores. Given that this program project has multiple sites and linkages to other funded efforts, it is essential
that we manage these efforts to insure harmonization of inclusion/exclusion criteria, clinical and
neuropsychological evaluations, and diagnostic criteria for cognitively unimpaired, mild cognitive impairment and
dementia. Core A facilitates these goals with committees, documentation, website resources and internal and
external (SAB) reviews. The Aims of this Core reflect the commitment of the MPIs, Drs. Zlokovic and Toga, to
provide the scientific and administrative leadership for the program consisting of 3 research projects and 3 cores,
which are all integrated and use complementary approaches, technologies and analyses focused on the program
project’s wide aims as described in the Overview. The Aims of Core A are: 1. To provide scientific and
administrative leadership to ensure unified and consistent participant screening and enrolment across different
participating sites; transparent communication across projects, cores, Co-Is and SAB members; and open data
sharing among all the Co-Is, their respective clinical and scientific personnel across different institutions as well
as the wider scientific community. 2. To track milestones and metric measures for the program as a whole and
for all projects and cores, we will maintain internal quality control of research and hold monthly meetings of all
PLs and CLs and Co-Is, quarterly meetings of subcommittees from AIM 1 and ad hoc and annual evaluation
meetings with our SAB members to effectively monitor development of the program and maintain high-quality
scientific progress. 3. To contribute to education. 4. To utilize business models to efficiently manage the
program’s business activities including management of day-to-day activities, contractual agreements, allocation
of funds, and regular income/expense reports.

Public health relevance
Project Narrative: Not required per funding opportunity instructions.